Improvements to the Regional Biocontainment Research Facilities at the University of Missouri

The objective of the parent G20 grant is to provide state of the art, highly safe and secure
biocontainment facilities and services to faculty, student and staff researchers at the MU Laboratory for
Infectious Diseases, one of 12 NIH/NIAID Regional Biocontainment Laboratories. The LIDR/MURBL is
currently host to more than 60 researchers. Our research community is successful in grant funding with 14
Principal Investigators currently active in federally and privately funded grants/contracts. The current ABSL3
facility supports aerosol challenge of rodents, but larger animal challenges cannot occur due to a lack of
appropriate containment housing. The goal of this G20 supplement project is to expand the capabilities of
the MURBL to serve the biodefense and emerging infectious disease research for the region. Towards this
objective, we propose to renovate the east suite of the ABSL3, including the installation of a specialized
ante room and effluent decontamination system, to allow for the housing of large animals in biocontainment.
These upgrades would serve the immediate needs of MU faculty of the RBL who are conducting
translational research on SARS-CoV-2, influenza virus, and hepatitis B virus.
Aim 1: Add open caging capabilities to the ABSL3 at LIDR for housing swine and other large animals
following challenge with respiratory viruses that are pathogenic to humans. We propose to build open
caging capacity in the ABSL3 at LIDR for housing up to 10 pigs or other large animals that have been
experimentally infected with various human pathogens. The request includes funds for remodeling in the
anteroom as well as the animal holding room/building effluent system to permit effluent decontamination, and
necessary HVAC upgrades.
Aim 2: Purchase and install equipment for whole animal imaging following infection. We propose to add
capabilities for whole animal imaging, which will allow for reduction of research animals used at LIDR.

Public health relevance
PThe long-term goal of this G20 project is to enhance capabilities for supporting biomedical research in infectious diseases, with a focus on those caused by pathogens that require biosafety level 3 containment. The University of Missouri Regional Biocontainment Laboratory (RBL) specializes in aerosolized models of diseases caused by high consequence viruses and bacteria, including SARS-CoV-2 as well as tier 1 select agent such as Yersinia pestis. Our current capabilities are limited to rodent models, and although this is impactful for emerging infectious disease research, these limitations impose restrictions on our ability to conduct well controlled studies in larger animals such as swine. This Administrative Supplement application is being submitted in response to NOT-AI-22-049 Notice of Special Interest (NOSI): Administrative Supplements for NIAID Regional Biocontainment Laboratories (RBL) and other NIH Grantees Conducting Research at RBL affiliated Sites. The objective of the supplement project is to renovate the MURBL ABSL3 to accommodate large animal studies of viral and bacterial infections. With this capability, the MURBL will be able to better support emerging infectious disease research where the large animal models are needed to understand host-pathogen interactions and immunity to respiratory infections. Moreover, the proposed enhancements expand our ability to support pre-clinical studies and is expected to have high impact in supporting translational research on NIH/NIAID priority pathogens.